Biomarker Predictors of Memantine Sensitivity in patients with Alzheimer's Disease

Abstract
This application responds to PAR-16-365: “Pilot Clinical Trials for the Spectrum of Alzheimer's Disease
...”, and its calls for “Studies to define and refine the target population” and “address heterogeneity of
response… identification of specific individuals… more [vs.] less likely to benefit from the intervention(s).”
Alzheimer's Disease (AD) is a severe neurodegenerative brain disorder, with limited therapeutic
options. The NMDA receptor antagonist, memantine (MEM) is approved for treatment of moderate-to-severe
AD; its mechanisms are not well understood, but may include a blunting of glutamate-mediated neurotoxicity.
While meta-analyses confirm MEM's effectiveness in delaying the progression of cognitive and behavioral
disturbances in AD, the clinical response to MEM is modest, short-lived and highly heterogeneous, with many
AD patients showing no gains even with an extended MEM trial. The utility of MEM in AD might be greatly
enhanced if patients could be identified as “MEM-sensitive” vs. “MEM-insensitive” in advance of a therapeutic
trial, using a predictive biomarker.
For the past decade, the PI has studied the acute neurophysiological effects of MEM in laboratory
animals, healthy human subjects (HS) and schizophrenia (SZ) patients. These studies demonstrated that a
single “challenge dose” of MEM (20 mg) significantly enhanced specific laboratory measures of early auditory
information processing (EAIP) in HS and SZ patients: prepulse inhibition (PPI), mismatch negativity (MMN) and
gamma band auditory steady-state response (ASSR; including gamma power and synchronization). This
application will determine whether the EAIP response to an acute MEM-challenge can be used to
predict a positive therapeutic response to MEM in patients with mild-to-moderate AD, over a 24 week trial.
Aim 1 tests the hypothesis (H1) that a single dose of MEM (20 mg vs. placebo (PBO)) will significantly
enhance EAIP measures in patients with mild-to-moderate severity AD (n=88). Assessed across the full cohort
of patients, PPI, MMN and ASSR should be significantly greater after MEM vs. PBO. However, the magnitude
of this “MEM effect” (MEM minus PBO) will vary across measures and patients. Aim 2 will leverage this
response heterogeneity to test the hypothesis (H2) that patients exhibiting a larger “MEM effect” on EAIP will
experience a significantly greater clinical response to MEM, compared to patients with a smaller “MEM effect”
on EAIP. After Aim 1 testing, MEM treatment will be initiated and titrated to 10 mg bid in all patients. Clinical
outcome measures will be assessed at baseline, 8, 16 and 24 weeks. Analyses will determine whether MEM
effects on EAIP measures (individually, and in composite scores) predict the magnitude of the clinical response
to MEM in these patients. Moderating factors will be tested, including specific single nucleotide polymorphisms
known to moderate MEM sensitivity. This application leverages a unique set of empirical laboratory findings
with MEM to develop a novel biomarker predicting sensitivity to MEM's therapeutic impact in patients with AD.

Public health relevance
Project Narrative Memantine (MEM) is an FDA-approved treatment for Alzheimer's Disease (AD), but its clinical effects vary from person-to-person. We have reported that a “test dose” of MEM significantly enhances early auditory information processing (EAIP) indices of brain function in both healthy adults and psychiatric patients, suggesting that these EAIP measures can be used as “biomarker” evidence that - in a given person - MEM is active within brain circuitry relevant to cognition. Here, we will test the hypothesis that the EAIP response to a “test dose” of MEM can be used to predict which patients with AD will be most vs. least sensitive to the clinical benefits of this medication over a 24-week trial.